Targeting the orphan nuclear receptor LRH-1 with small molecules

PROJECT SUMMARY
Obesity is a growing epidemic in the United States, leading to increases in cases of nonalcoholic fatty liver
disease (NAFLD), cardiovascular disease, and type II diabetes. A common characteristic of these diseases is
aberrant lipid and glucose metabolism. This proposal centers on the nuclear hormone receptor, Liver Receptor
Homolog 1 (LRH-1), which acts as an important regulator of lipid metabolism, reverse cholesterol transport,
glucose sensing, and homeostasis. As such, LRH-1 represents a novel therapeutic target for metabolic
diseases. LRH-1 binds to phospholipids (PLs) and is activated by the unusual PL dilauroylphosphatidylcholine
(DLPC) which shows potent anti-diabetic effects. The discovery that LRH-1 is regulated by PL ligands reveals
an exciting potential to tune LRH-1 activity for the treatment of metabolic diseases. However, PLs are labile
and not suitable for clinical use, necessitating the development of small molecule agonists. This has proved
challenging thus far, since very few small molecules can displace endogenous lipids from the large, lipophilic
binding pocket. Recent studies in our lab have characterized a class of small molecules that are capable of this
feat. Using robust SAR and innovative chemistry, we have designed potent LRH-1 agonists that display
biological activity. We have modified our most potent and efficacious agonists to improve their biophysical
properties, making them suitable for in vivo studies. The advancement of LRH-1 agonists as therapeutics has
also been hindered by the lack of appropriate rodent models to screen potential candidates due to small
sequence differences in the binding pocket of rodent and human LRH-1. To overcome this barrier, we used a
CRISPR-Cas9 strategy to humanize the mouse LRH-1 ligand binding pocket. This permits activation by
synthetic agonists while minimizing changes to endogenous interaction surfaces. These leaps forward in lead
compound development and mouse model generation, in combination with our deep knowledge of LRH-1
structure and function, create an ideal platform to develop candidate preclinical LRH-1 modulators for
metabolic disease. Here, we have developed a strategy to define mechanisms of action, target engagement,
pharmacology, and disease efficacy of our lead compounds. In aim 1, we generate compounds with improved
biophysical properties that mimic PL-like activation. We will perform mechanistic characterization of these
compounds to explore how contacting the PL-binding site with different polar moieties improves LRH-1
activation. In aim 2, we will examine the behavior of our lead compounds from an ADME perspective. The
primary objective will be to establish tractability of the compounds using our humanized mice, so that
pharmacokinetic relationships can be established. In aim 3, we will use our humanized mice and a model of
diet-induced obesity to evaluate the in vivo efficacy of our lead LRH-1 compounds to improve glucose
tolerance and insulin resistance.

Public health relevance
PROJECT NARRATIVE Liver receptor homolog 1 (LRH-1) is a nuclear hormone receptor that acts as an important regulator of lipid and glucose metabolism and has shown promise as a new therapeutic target for obesity-related metabolic diseases; however, a poor understanding of how ligands regulate LRH-1 has hampered development of modulators. This proposal is centered on improving recently developed high-affinity LRH-1 modulators to support in vivo studies for use in a new humanized LRH-1 mouse model. These tools will enable the study of LRH-1 biology and have therapeutic potential for diseases such as diabetes and fatty liver disease.